Core 1 Biostatistics

The continuing mission of the RadCCORE Biostatistics Core is to provide applied and theoretical biostatistics
and bioinformatics expertise in support of the continued scientific mission of this grant. To this end, the core will
serve as a centralized resource for expertise in applied and theoretical cancer biostatistics as well as data and
scientific computing. The core faculty and staff will bring to bear not only technical expertise but also their vast
experience in and passion for basic, clinical and translational cancer research to help to drive the science. The
core personnel will be involved in every facet of the proposed research starting from the conception stage of
studies and experiments through the interpretation and dissemination of the resulting findings. The core
personnel will collaborate pro-actively with clinical and lab personnel of this project to ensure that studies and
experiments are set up and executed optimally. The scope of scientific discovery and rigor should neither be
limited nor compromised due to lack of appropriate and adequate statistical methodology or computational tools.
When needed and appropriate, the core personnel will extend existing methods or develop novel statistical
methods or computational tools to enable the investigators of this project address scientific questions with rigor
and efficiency. The core will also provide ongoing education in the area of statistical methodology and concept
to the project investigators.

Public health relevance
Biostatisticians of this core collaborate with the investigators to produce well-designed studies and experiments with clearly defined objectives optimized to address the scientific questions in clinical and translational cancer research and ensure that the resulting data are analyzed rigorously and interpreted appropriately. They provide analysis support of both prospective and retrospective clinical data, and analysis support of both candidate and high throughput genomic data. When existing methods and tools are inadequate to address the scientific questions asked, the biostatisticians will develop requisite methods and tools.